Therapeutic Strategy to Treat Alzheimer's Disease by VGF Delivery into Brain

SUMMARY/ABSTRACT:
Alzheimer’s disease (AD) is a progressive neurodegenerative disease that has emerged as the most prevalent
form of late-life dementia in humans, in which the formation and accumulation of hyperphosphorylated tau protein
and amyloid-β (Aβ) are believed to play key roles in AD pathogenesis. Of note, the recent multiscale causal
network analysis in Accelerated Medicines Partnership for Alzheimer’s Disease (AMP-AD) cohort identified that
VGF is the only downregulated key driver for AD. VGF is synthesized by neurons in the brain where it promotes
growth and survival of neurons, and is involved in neurogenesis, synaptogenesis and energy homeostasis. VGF
plays a critical role in learning, memory, and pathophysiology of neurodegenerative diseases. Therefore, this
proposal aims to develop a novel effective gene therapy for AD by targeting VGF. The major challenge in
the field of gene therapy for AD is to design a safe vector that can cross the blood brain barrier (BBB) and target
the desired cells. We propose to develop innovative and targeted nanoparticles conjugated with human VGF
cDNA plasmid (pVGF) for the treatment of AD by delivering into brain after intravenous and intranasal
administration. Intranasal route provides a direct entrance of CNS therapeutics to the brain and therefore this is
a promising non-invasive pathway for gene to reach the brain parenchyma by bypassing the BBB. We would
synthesize two types of nanoparticles- liposomal nanoparticles and ω-3 fatty acid grafted chitosan based
nanomicelles. Both types of nanoparticles will be grafted with targeting ligands [transferrin (Tf), mannose (MAN),
and brain and neuron specific cell penetrating peptide (CPP)]. It has been found that the Tf and GLUT-1 receptors
are present on the surface of brain endothelial cells as well as on neurons. MAN is a substrate for GLUT1. In
addition, the CPP will further improve the penetration of nanoparticles/nanomicelles into brain. Therefore, we
propose to design liposomal nanoparticles encapsulating gene and modifying the surface of nanoparticles with
Tf, MAN and CPP. Similarly, ω-3 fatty acid grafted chitosan will be also modified by grafting with Tf, MAN and
CPP. These graft polymers will form self-assembled cationic nanomicelles in aqueous environment to provide
selective targeting of complexed pVGF to brain. The long-term goal of the proposed research is to design a
non-viral gene delivery carrier for efficient delivery of pVGF to brain through intravenous and intranasal
administrations for prevention and treatment of aging-related cognitive decile including AD. We propose three
specific aims to accomplish the long-term goal of the proposed research. Aim 1. Synthesize and characterize
nanoparticles/nanomicelles loaded with pVGF: The CPP-liposomal nanoparticles will be synthesized using
thin film hydration technique followed by insertion of Tf- and MAN- coupled micelles using post-insertion
technique. We propose to use three BBB and neuron specific CPPs: (i) a non-toxic fragment of tetanus toxin
known as tetanus toxin C fragment (TTC), (ii) penetratin, and (iii) rabies virus glycoprotein (RVG-9R containing
a nerve binding region). For nanomicelles, we will synthesize graft polymer (GP) of chitosan with ω-3 fatty acid.
The GP will be further grafted with MAN, Tf and CPP, and characterize by infrared (IR) and NMR spectroscopy.
The GP will self-assemble in aqueous media to form nanomicelles. The nanoparticles/nanomicelles will be
evaluated for particle size, zeta potential, encapsulation efficiency, cell uptake and uptake mechanism(s),
transfection efficiency, cell cytotoxicity, and hemolysis assay. The transport efficacy of pVGF loaded
nanoparticles/nanomicelles will be evaluated across an in vitro BBB model designed by combining primary
human epithelial cells (HBMECs) and primary human astrocytes (HA). We will evaluate the effect of
nanoparticles/nanomicelles on transfection efficiency, Aβ levels and tau-phosphorylation in the cell culture BBB
model by seeding the APP Swe/Ind or MAPT P301L-overexpressing SHSY5Y cells in 24-well plates. Secretion
of Aβ40 and Aβ42 in the culture supernatant, as well as intracellular accumulation in cell lysates, will be
determined by ELISA. Total tau and phosphorylated tau levels in the cell lysates and culture medium will be
measured by Western blot assay/ELISA. Aim 2. Evaluate the in vivo biocompatibility, organ toxicity,
pharmacokinetics and VGF expression in wild type mice of varying ages: To establish successful gene
therapies for AD, we will validate the nanoparticles/nanomicelles for their biocompatibility, organ toxicity, and
pharmacokinetics (biodistribution) after administering intravenously or intranasally into wild type mice at 3
months of age. In addition, the VGF gene delivery will be further validated in wild-type mice at 3 and 24 months
of ages. Aim 3. Assess the therapeutic effects of the nanoparticle/nanomicelle-mediated VGF gene
delivery on cognitive impairment and Aβ pathology: To establish successful gene therapies for AD-related
phenotypes and age-related cognitive decline, we will examine effects of VGF gene therapy through the
functionalized-nanoparticles/nanomicelles on neurobehaviors, synaptic functions and/or amyloid pathology. The
nanoparticles will be administered intravenously or intranasally into amyloid model 5xFAD mice and aged wild-
type mice, and the effects will be assessed. For human relevance, we will also use iPSC-derived neurons and
cerebral organoids from AD patients and assess the effects on neurodegeneration and Aβ/tau pathologies.
Collectively, we anticipate that the proposed study will contribute towards the development of high efficiency
non-viral gene delivery system to deliver pVGF into brain for successful gene therapy for AD and other
neurodegenerative diseases.

Public health relevance
Project Narrative: Alzheimer’s disease (AD) is the most common type of dementia in the elderly, which accounts for 60-80% of cases. Currently, an estimated 5.7 million Americans of all ages have AD. VGF(non-acronymic) is synthesized by neurons in the brain where it promotes growth and survival of neurons, and is involved in neurogenesis, synaptogenesis and energy homeostasis. Therefore, strong scientific premises indicate that increasing VGF levels in the brain could be a promising therapeutic strategy to treat AD. The long-term goal of the proposed research is to design a non-viral gene delivery carrier for efficient delivery of pVGF to brain through intravenous and intranasal routes for prevention and treatment of aging-related cognitive decile including AD. The studies will be conducted in vitro and in vivo in Wild Type, amyloid 5xFAD and PS19 mice models.